Natural-based therapies for sensory disorders

PROJECT SUMMARY
Hearing loss is a major health concern in our society, affecting over 400 million people worldwide.
Aminoglycoside therapy causes permanent hearing loss in 40-60% of treated patients. To date, no
drugs have been approved by the Food and Drug Administration for protection from aminoglycoside-
related hearing loss (AGIHL). Most candidate compounds currently in pre-clinical and clinical trials are
related to antioxidants, vitamins, and glutathione metabolism. We have conducted a high-throughput
screening of bioactive natural compounds employing zebrafish as our platform for aminoglycoside
ototoxicity and identified piperlongumine, an alkaloid extracted from the long pepper Piper Longum L.,
as an important therapeutic molecule for aminoglycoside-induced hair cell death. Previous studies have
shown that piperlongumine can allosterically modulate the transient receptor potential vanilloid 1
(TRPV1) channel at high doses. Our own studies in a mouse model for AGIHL demonstrated that
piperlongumine can partially protect hearing function when given as a single dose for 17 consecutive
days. The morphological assessment demonstrated that piperlongumine protects hair cells and their
synapses. Given that TRPV1 is upregulated in the inner ear during inflammation, in this proposal we
want to 1) design, synthesize and test piperlongumine derivatives with a better fit for TRPV1 allosteric
pocket; 2) characterize the pharmacological and physicochemical properties and distribution of the top
lead candidates; 3) establish efficacy and therapeutic window of the top candidates in an animal model
that recapitulates AGHIL and endotoxemia; 4) establish the TRPV1-mediated mechanism(s) of action
of the piperlongumine derivatives, and 5) confirm that piperlongumine derivatives do not antagonize
with aminoglycoside anti-bacterial activity. By completing these studies, we will be able to obtain the
necessary information to move piperlongumine derivatives forward toward future clinical trials. We have
already established conversations with future collaborators involved in clinical research with cystic
fibrosis patients and newborn intensive care unit patients. Moreover, I am one of the inventors on a
patent for the use of piperlongumine to treat hearing loss filed by Ting Therapeutics LLC as a Patent
Cooperation Treaty. Thus, this proposal has the potential to be a significant step forward for the
treatment of AGIHL in patients with severe Gram-negative bacterial infections.

Public health relevance
PROJECT NARRATIVE This proposal exploits the beneficial characteristics of a natural product, piperlongumine and piperlongumine derivatives, for protection against hearing loss in patients receiving antibiotic treatment for severe infections. Accomplishing these pre-clinical studies will allow us to gather the necessary scientific information to advance piperlongumine or its derivatives into future clinical trials.